Structural study of direct associations between cellular RNA polymerase and regulatory factors during the transcription cycle

Summary
The long-term goal of our research is to understand transcription mechanisms of cellular RNA polymerase. Our
research has made major contributions to provide structures of RNA polymerase at the different stage of
transcription cycle. During the next five years, we will continue to study the transcription machinery in bacteria
and archaea to provide insights of the fundamental mechanism of transcription, which is conserved from bacteria
to human.
Over the last 20 years, X-ray crystallography has been playing a major role in the structural biology of
RNA polymerase and revealed many important structures. RNA polymerases at evident stages in the
mainstream of the transcription cycle are often referred to RNA polymerase core enzyme, holoenzymes, open
complex with a strong promoter, transcription initiation and elongation complexes. These structures have been
well characterized due to their stable natures. A challenge in the structural biology of cellular RNA polymerase
is to visualize transient interactions of RNA polymerase with other regulatory factors and ligands that occur in
between each evident stage in the mainstream or at the branched pathways from the mainstream of transcription
cycle. Due to their elusive natures, crystallization of such macromolecular assemblies has been a bottleneck and
thus limited the approach by X-ray crystallography.
In the last couple of years, the resolution of macromolecular structures determined by cryo-electron
microscopy (cryo-EM) has been drastically improved due to multiple technical advances, allowing us to visualize
heterogenous and large assembly of macromolecular complexes. We will use structural biology methods
including both cryo-EM and X-ray crystallography together with other biochemical approaches to visualize these
transient interactions and investigate their effects for transcription process. Major targets of our study are: 1) the
interaction between the Escherichia coli RNA polymerase and DksA/ppGpp for transcription regulation during
the stringent response; 2) the interaction between bacterial RNA polymerase and ATP-dependent motor enzyme
for rescuing stalled RNA polymerase at the end of transcription cycle; and 3) the interaction between archaeal
RNA polymerase and ATP-dependent transcription termination factor Eta for disrupting a stalled transcription
elongation complex to initiate the transcription-coupled DNA repair.

Public health relevance
Project Narrative: Gene expression by cellular polymerase is fundamental to all life forms and investigating the transcription process is critical for understanding cell development, maintenance, and disease. The proposed studies regarding the structure and function of cellular RNA polymerase may lead to new avenues for drug discovery and preventing disease.